Suicide prevention in Department of Veterans Affairs community care network mental health settings

BACKGROUND: Suicide is a chief concern in Veterans, particularly following a mental health stay. The
Department of Veterans Affairs (VA) has invested heavily in strategies to prevent suicide in Veterans who are
at risk of suicide following a Veterans Health Administration (VHA) mental health stay. These interventions,
however, do not reach another high-risk population, namely Veterans who access VA-purchased care in the
community (i.e., Community Care). This is particularly concerning because an increasing number of Veterans
are using VA-purchased care. While Veterans are at high risk of suicide following a Community Care mental
health stay, there is little knowledge about effective strategies to mitigate suicide risk in this population. A
promising suicide prevention strategy, called the VA Brief Intervention and Contact Program (BIC), has been
developed. VA BIC is designed to meet the unique needs of Veterans. Pilot studies of VA BIC in VHA settings
have suggested that VA BIC may address key factors related to suicide risk during care transitions including
social connectedness and treatment engagement. Based on these promising results and given the critical gaps
in suicide prevention care in Veterans who are psychiatrically hospitalized in Community Care settings, it is
essential to determine whether VA BIC can reduce suicide risk in this high-risk population.
OBJECTIVES: The long-term goal is to design, study, and improve interventions to prevent death by suicide in
Veterans. The overall objective of this proposed clinical trial is to determine whether the VA BIC intervention is
an effective strategy to reduce suicide risk in Veterans who are admitted to Community Care mental health
units. The short-term goal is to test whether the VA BIC intervention can decrease suicidal ideation after a
Community Care mental health stay and increase [engagement in mental health care and social
connectedness.] The central hypothesis is that VA BIC will [decrease suicidal ideation after discharge] as
compared to treatment as usual (TAU). It is hypothesized that VA BIC will [increase engagement in mental
health care and social connectedness after discharge] as compared to TAU. The expected outcome of the trial
is to ascertain the efficacy of VA BIC in decreasing suicidal ideation and [increasing engagement in mental
health care and social connectedness] following a Community Care mental health stay. The trial will inform the
design of a future Cooperative Studies Program (CSP) multi-site trial that is powered to test the effect of VA
BIC on suicide attempts in Veterans with a psychiatric hospitalization in a Community Care facility.
METHODS: A randomized controlled trial of VA BIC will be carried out in Veterans who are psychiatrically
hospitalized at Community Care hospitals located in [Northern] New England. Eligible Veterans will be
recruited over a three-year timeframe and will be randomized to VA BIC plus TAU, or TAU alone. Participants
will be followed for a total of [nine] months. Outcomes will be gathered at baseline and at [3, 6, and 9] months
[post baseline.] [A generalized linear mixed model (GLMM)] will be used to determine whether VA BIC results
in a significant decrease] in suicidal ideation. A GLMM will [also] be used to learn whether VA BIC results in a
significant [increase] in [engagement in mental health care and social connectedness]. An exploratory analysis
will examine the effect of VA BIC on suicide attempts.
IMPACT: Little is known about effective strategies to prevent suicide in Veterans who are treated in
Community Care settings. This proposal will address this concerning knowledge gap by testing a highly
promising suicide prevention strategy in Veterans who are psychiatrically hospitalized in Community Care
hospitals. The results of the trial will not only determine the impact of VA BIC on suicide risk in this population
but also lead to a future CSP trial that is powered to detect the effect of VA BIC on suicide attempts. In the end,
the proposal trial will enable the VA to identify a highly effective intervention to prevent suicide in a vulnerable
Veteran population that may have little or no interaction with VA providers during a chief period of risk.

Public health relevance
The proposed study is of high importance to Veterans' health because it will study a suicide prevention intervention in a Veteran population that is at high risk of suicide but has not been a specific focus of the Veteran Affairs' (VA's) suicide prevention efforts. Specifically, a growing number of Veterans are now receiving inpatient mental health treatment in VA-purchased settings (commonly referred to as Community Care). While these Veterans are at high risk of suicide after hospital discharge, very little is known about how to prevent suicide in these Veterans. This study will directly address this problem by looking at whether a novel and promising suicide prevention strategy called the VA Brief Intervention and Contact Program (BIC) can decrease the risk of suicide in Veterans after they receive mental health care in a Community Care hospital. The proposed research is highly pertinent to the VA's top clinical priority—to prevent suicide in Veterans. The findings from this proposed study will help the VA to locate an effective strategy to prevent suicide in Veterans.